Project 3: Obesity-related Metabolic Reprogramming in Endometrial Cancer Disparities

PROJECT ABSTRACT – PROJECT 3
The incidence and mortality of endometrial cancer (EC) continues to increase at an alarming rate. Dramatic EC
disparities show that Black women experience the highest increases in EC rates and worse outcomes across all
stages and grades. There is a critical and urgent need to understand molecular drivers behind EC disparities so
that agents can be tested to prevent or intercept the onset or progression of EC and improve outcomes. Obesity
is tightly linked with EC risk, but decades of research on obesity have yielded modest insight into the specific
mechanisms driving EC development, especially in understanding disparities. Roughly 40% of women in the US
are classified as having obesity, but only a small fraction of these women develop EC.
Heterogeneity in systemic and tissue-level metabolic disruptions related to obesity and cumulative physiologic
stressors may be a key factor for EC risk and contribute to aggressive tumors. Black women experience higher
rates of obesity and type 2 diabetes, higher circulating markers of systemic inflammation (e.g., TNFα, C-reactive
protein, IL-6), and increased rates of other cardiometabolic risk factors compared to White women. We propose
that measurable social and environmental factors contribute to chronic metabolic and pro-inflammatory
conditions to disrupt endometrial signaling and stress responses. Allostatic load has been used to assess
cumulative physiologic exposure to measurable social and environmental factors, and is scored using markers
of metabolic, cardiovascular, and inflammatory stressors, among others. Allostatic load is associated with
morbidity and mortality in aging-related disease, cardiovascular disease, and cancers. At the cellular level,
mitochondrial allostatic load describes cumulative stressors or exposures disrupting mitochondrial metabolism
and cellular signaling.
Our overall hypothesis is that endometrial adaptations to metabolic disruptions in obesity and physiologic stress
increase tumorigenesis and promote aggressive tumor behavior underlying EC disparities. The long-term goals
are to identify biomarkers for improved EC risk stratification, and to provide candidate targets for cancer
interception to improve EC outcomes. Our study utilizes multiple models and measures for these cumulative
stressors at the systemic, tissue, and cellular (mitochondrial) levels to define pro-tumorigenic signaling with the
following aims: Aim 1. Compare cumulative systemic measures of metabolic disruption and physiologic stress
(allostatic load) across Black and White women with EC versus women with benign endometrium. Aim 2. Define
endometrial tissue-level reprogramming based on systemic metabolic and physiologic stress to identify regional
pathway alterations underlying disparities. Aim 3. Define the impact of disrupted mitochondrial function on
endometrial stress responses and aggressive tumor behavior using EC patient-derived organoid models.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 Dramatic disparities have been observed for uterine (endometrial) cancer in the US, with Black women experiencing the disparate burden of new cases, aggressive cancers, and worse survival across all stages and subtypes. Multiple studies have shown that Black women experience higher rates of obesity, type 2 diabetes, inflammation, and other cardiometabolic risk factors, and we predict that these cumulative stresses reprogram endometrial tissue responses to increase endometrial cancer development and tumor aggressiveness. This study identifies molecular changes in clinical samples from women and uses innovative laboratory-based models to define the biology underlying endometrial cancer disparities as a critical step to eliminating them.